Neuromodulation in visual cortex

Summary/Abstract
Ascending acetylcholinergic and noradrenergic neuromodulatory systems are thought to alter information
processing in cerebral cortex with spatial and temporal precision (Obermayer et al., 2017). Yet we lack basic
information about how these systems affect neural responses underlying perception and decision-making in
sensory cortex of awake, behaving subjects. The overarching goal of this project is to investigate how cholinergic
and noradrenergic inputs to visual cortex are activated during a visual detection task. Genetically coded
neurotransmitter reporters (GRAB-Ach, GRAB-NE) are novel tools that can measure local neurotransmitter
concentrations in cortex with sub-second resolution. These newly developed genetically coded neurotransmitter
reporters offer an unprecedented window into real-time changes in local neurotransmitter concentration during
perceptual decision-making. Aim 1 will define the relationship of ACh and NE neurotransmitter concentrations
in primary visual cortex to behavioral decision variables. Aim 2 will define the relationship of ACh and NE
neurotransmitter concentrations in primary visual cortex to the fidelity of the neural representation. This work
will provide preliminary data for larger scale studies that examine the effect on neurotransmitter concentrations
of manipulating cognitive variables such as attention, decision-making, and working memory. These initial
experiments will set the stage for future studies that manipulate neurotransmitter concentrations with systemic
or intracranial drug injections to test causal relationships between neurotransmitters and behavioral
performance.

Public health relevance
Narrative The goal of this project is to investigate how cholinergic and noradrenergic circuits contribute to perceptual decision-making. Decision-making, is critical in environments where performance depends on detecting and responding appropriately to near threshold stimuli. In this project, we will investigate how cholinergic and noradrenergic neuromodulators contribute to immediate and long-term behavioral performance using laminar electrophysiology and fiber photometry with GRAB-Ach and GRAB-NE neurotransmitter reporters.